Potent Antibody Protection Against P. falciparum and P. vivax Malaria

Project Summary/Abstract
Malaria remains a significant threat to global public health, causing over 600,000 deaths in 2022 alone,
predominantly among African children under the age of five. Improving vaccines and implementing long-acting
immune-based therapies to prevent transmission are critical to reduce malaria incidence and support global
elimination efforts. Our team, and others in the field, have now identified panels of highly potent human antibodies
against the pre-erythrocytic circumsporozoite protein of Plasmodium falciparum (PfCSP). The most potent of
these anti-PfCSP antibodies (CIS43) shows over 85% protective efficacy in controlled human challenge studies
and field trials. Deep molecular characterization of protective antibody candidates highlighted certain epitopes
associated with improved antibody affinity and potency, which will be required for clinical malaria interventions.
However, additional antibody potency improvements are still needed for broad deployment against P. falciparum,
and the molecular mechanisms for protective antibodies against CSP of the second most significant human
malaria species, Plasmodium vivax (Pv), are not well understood. Elucidating the functional molecular profiles
of protective antibodies against Pf and PvCSP, particularly the relationships between affinity, targeted epitopes,
and in vivo protection, is crucial to design effective, potent, and long-lasting vaccines and immunotherapies. This
R01 research project builds directly on our previously published work improving antibody potency against PfCSP,
and will analyze the molecular composition of protective antibody responses against both Pf and PvCSP. In
particular, our goal is to identify new antibody variants with additional 5-fold or greater improvement on previous
CIS43 and L9 variants to support broad medical use, and to understand the mechanisms that support exquisite
protective potency for anti-malarial antibodies targeting sporozoites. In Aims 1 and 2, we will apply our validated
yeast display and directed evolution platform to engineer anti-PfCSP antibodies for enhanced affinity and in vivo
protection, with detailed characterization of the mechanisms behind potency improvements. We will focus on
antibody lineage variants targeting the PfCSP junctional epitope (CIS43) and minor repeat (L9), which have
already been validated as highly protective targets in human clinical trials. We will study the relationship between
increased affinity and protective potency, with a focus on manipulating multi-epitope affinities across the highly
similar CSP peptide repeat regions. In Aim 3, we will extend these approaches for multidimensional immune
mapping of anti-malarial antibody repertoires elicited by recent exposure to Pv in Brazilian adults. We will identify
the genetic, functional, and structural features of naturally elicited protective antibodies against PvCSP, and
other sporozoite protein targets, that will guide new potential intervention mechanisms for vaccines against Pv.
Successful completion of this R01 study will deepen our understanding of antibody-based malaria immunity to
guide vaccine design and provide potent antibody drug candidates to help address the global burden of malaria.

Public health relevance
Project Narrative Malaria is a leading cause of disease and death around the world, with over 600,000 deaths each year. Anti- malarial antibodies have shown promise against Plasmodium falciparum (Pf), but they require improvements for broad clinical use and preventions are even more limited against Plasmodium vivax (Pv), the other dominant global species that infects humans. This project will determine the critical protective features for antibodies targeting Pf and Pv sporozoites to guide new vaccine and antibody drugs against malaria.